TECHNICAL CORE

We are requesting support far a Core Unit to integrate the administrative and scientific activities of the Program Project, thus relating directly to the communal needs of the six individual projects. These needs include program administration, centralized technical facilities (e.g. tissue culture laboratory), equipment (e.g. phosphorimager), supplies (e.g. liquid nitrogen), program project personnel travel, service contracts (e.g. electron microscope),. and external consultation.